Structural Biology and Biophysics of Alpha-Synuclein Fibrils by Solid-State NMR

ABSTRACT
Synucleinopathies are a major public health risk, with millions of people each year affected by Parkinson disease,
Parkinson disease with dementia (PDD), Lewy Body dementia, and multiple system atrophy. These diseases
impact both motor and cognitive function, for which there are no known cures and limited therapeutic options. It
is therefore vital to determine the disease etiology, which is hypothesized to arise from the misfolding and
aggregation of the protein α-synuclein into fibrils. The in vivo structural forms of these pathogenic fibrils will help
to understand mechanisms of misfolding and aid in the development of imaging ligands with higher structure-
specific binding. I will use solid state NMR (SSNMR) in combination with cryo-EM/ET to determine the structures
of patient derived in vivo PDD fibrils. I will then investigate how in vivo fibril quaternary structure governs the
stability and dynamics of mature diseased state fibrils and its effects on the aggregation pathway of α-synuclein
fibrils. I will also investigate the interactions of imaging ligands to these fibrils to determine the structural motifs
these compounds bind to by comparing binding site structure between in vitro and in vivo fibril preparations.
Training plan: I have a considerable amount of research experience with SSNMR of membrane proteins, and I
will add training in SSNMR methods required for structure determination of fibrils structures using novel
approaches combining simulated annealing and molecular dynamics with cryo-electron microscopy (cryo-EM),
cryo-electron tomography (cryo-ET) and SSNMR data. The National Magnetic Resonance Facility at Madison
(NMRFAM) provides a world-leading environment for training with access to high field SSNMR spectrometers
(600 to 900 MHz) and an ultra-high field (1.1 GHz) SSNMR spectrometer arriving in 2023. The infrastructure
here will allow me to make new discoveries to both structure and dynamics of diseased fibrils and their
interactions with imaging ligands. Furthermore, I will gain training in cryo-ET to obtain complementary data such
as fibril width, twist, mass-per-unit length, and utilize cryo-EM to solve structures jointly with SSNMR to atomic
resolution. These findings will be disseminated to the larger scientific community via publications and talks given
at interdisciplinary meetings. My training will take place under Prof. Chad Rienstra, an internationally recognized
leader in the field of biomolecular SSNMR, who has mentored dozens of graduate students and postdocs, many
of whom are faculty members at top tier institutions. Environment: The University of Wisconsin-Madison is a
highly ranked research university, with among the best environments available in the world for structural biology,
with NMRFAM, the Cryo-EM Research Center, and the Center for High Throughput Computing. Prof. Katherine
Henzler-Wildman, co-director of NMRFAM with Prof. Rienstra, has a strong background in insoluble protein
structure and dynamics. Close collaboration with the cryo-EM group of Prof. Timothy Grant on fibril structure
determination will be an added capability. The excellent research environment at UW-Madison with Prof.
Rienstra will prepare me to be a future leader in structural biology and biophysics of complex biomolecules.

Public health relevance
PROJECT NARRATIVE This project investigates alpha-synuclein fibril structures and how various factors contribute to fibril stability and aggregation, leading to diseased fibril states that are centrally implicated within several neurodegenerative diseases (Parkinson disease, Lewy body dementia, multiple system atrophy) affecting millions of people each year. Fibril structures will support efforts in the broader research community to develop diagnostic tools and eventual therapies for these neurodegenerative diseases. This proposed study aims to determine the structure of in vivo fibrils amplified from patient tissue, to measure the molecular dynamics and quaternary structures, and to detect the site-specific binding of imaging ligands with atomistic detail.